Preclinical Assessment of Phage Therapy for Pathogen Decolonization

To support a variety of preclinical studies to assess the safety and efficacy of phage therapy for bacterial infections, including resistant infections.